Novel Ultrasonic Technique for the Treatment of Hemorrhagic Stroke

Project Summary
Intracerebral hemorrhage (ICH) is the most common type of hemorrhagic stroke with 4 million
annual cases worldwide. Evacuation of the ICH leads to reduction in intracranial pressure (ICP)
as well as prevention of secondary cerebral injuries. Current strategy for removing ICH requires
an invasive craniotomy and the need for traversing normal brain. Minimally invasive methods
include: 1) craniopuncture/tPA method which requires days for evacuation of ICH and risk of
rehemorrhage; 2) endoscopic ultrasonic aspiration has the force to injure cerebral tissue as well
as the need for learning endoscopic techniques. There is a clear unmet clinical need for a
minimally invasive method that can safely, effectively, and rapidly reduce the ICH volume
without using thrombolytic drugs and be applied with the simplest methodology. We
propose histotripsy as a novel ultrasonic technique that can fully address this unmet
clinical need. Histotripsy uses microsecond duration, high-pressure ultrasound pulses applied
from outside the skull and focused inside the ICH to produce cavitation to liquefy the ICH without
causing brain injury. The liquefied ICH can be immediately drained via a small bore catheter. We
have used histotripsy with electronic focal steering to achieve rapid transcranial ICH liquefaction
(~40 mL in 10 min) and drainage through excised human skulls. We have developed a miniature
hydrophone integrated within the catheter to precisely focus the ultrasound through excised
human skulls and the catheter can also be used for drainage of the liquefied ICH. We have also
demonstrated the in vivo feasibility and safety in a porcine ICH model. We propose three
specific aims toward developing Histotripsy as a novel technique for safely evacuating ICH
and improving outcomes. 1) Design and construct a portable histotripsy ICH system with real-
time 3D feedback that can transcranially liquefy and drain ICH with high precision and efficacy.
2) Validate the targeting precision, treatment location profile, and efficacy of the transcranial
histotripsy ICH system in human ICH phantom and fresh human cadaver. 3) Validate the safety
and efficacy of the transcranial histotripsy ICH system in an established in vivo porcine ICH model.
If these aims are successfully completed, we will establish a portable histotripsy ICH system
suitable for clinical use and proceed towards a clinical trial.

Public health relevance
Project Narrative The rupture of blood vessels in the brain can lead to bleeding and clotting (hematoma) inside the brain, termed as hemorrhagic stroke or intracerebral hemorrhage (ICH). ICH accounts for 10-15% of all strokes and is particularly devastating, leading to a 30-day survival rate of 30-50%. The goal of this proposal is to develop a new, minimally invasive, ultrasonic technique that can allow of liquefaction of the ICH thus allowing it to be removed via a ventriculostomy catheter placement thus reducing brain compression from the ICH as well as minimizing secondary effects of blood products within the brain.